Bridging the gap: joint modeling of single-cell 1D and 3D genomics

PROJECT SUMMARY/ABSTRACT
Advances in single-cell technologies have enabled three-dimensional (3D) genome structure profiling and
simultaneous capture of the transcriptome and epigenome within a cell. Quantitative tools are, however, still
unable to fully leverage the unprecedented resolution of single-cell high-throughput chromatin conformation
(scHi-C) data and integrate it with other single-cell modalities. To address this challenge, I propose to (1) Develop
a single-cell gene-body associating domain (scGAD) scoring system to explore single-cell 3D genomics data in
units of genes. (2) Construct machine learning-based models to impute histone modification and 3D chromatin
interaction for simultaneously profiling of each cell's epigenomic features and 3D chromatin architectures.
Subsequently, I will develop an epigenomic regulatory score (ERS) model to infer the cell-type-specific promoter-
enhancer regulation programs at the highest single-cell and single-gene resolution. (3) Validate and extend
scGAD and ERS pipeline to CAR-T immunotherapy study to gain insights into the impact of distal gene regulation
variations on patient responses. In Aim 1, preliminary analysis on human and mouse brain tissues demonstrated
that scGAD extracts gene features agreeing well with the scRNA-seq data from the same system. As a result,
scGAD facilitates the projection of cells from 3D genomics data onto reference panels constructed by scRNA-
seq embeddings with known cell-type annotations. Hence, scGAD provides an unprecedentedly accessible and
accurate cell type annotation method based on 3D chromatin architectures. Furthermore, the successful
integration of cells from different modalities into the same network facilitates information sharing across 3D
chromatin structures, the transcriptome, and the epigenome. Aim 2 leverages such multi-modal networks to build
an ERS model. ERS jointly models the histone profiles at the promoter and distal neighborhoods of the target
gene and the 3D spatial proximity between them. Therefore, the ERS scores quantify the regulatory effects of
distal elements on a per gene and cell basis. Aim 3 will extend the integration framework in Aim 1 and 2 using
scRNA-seq as a multi-modality bridge to CITE-seq data for a deeper annotation, especially for the Peripheral
Blood Mononuclear Cells. This enables the in-depth investigation of the apheresis samples from the Acute
Lymphoma Leukemia patients to gain insight into the roles of distal regulatory elements on gene expression and
their impact on the CAR-T cell therapy responses. To succeed in achieving these aims, I will pursue additional
training with mentor Dr. Steven Henikoff (epigenomics and gene regulation), co-mentors Dr. Raphael Gottardo
(statistics), Dr. Manu Setty (machine learning), Dr. Evan Newell (immunology), and collaborator Dr. Cameron
Turtle (CAR-T cell therapy). Fred Hutchinson Cancer Research Center is an ideal institute for multi-omics single-
cell study with application to immunotherapy, providing cutting-edge research facilities and opportunities for
further career development in a rich interdisciplinary environment. A K99/R00 award will be instrumental in
addressing these challenges and furnishing me with high-level training to launch my independent scientific career.

Public health relevance
PROJECT NARRATIVE Simultaneous profiling of the transcriptomic and epigenomic readouts along the one-dimensional (1D) genome and high-throughput three-dimensional (3D) chromatin conformation assays have both advanced to single-cell resolution. This project will propose statistical and machine learning-based models with accompanying software for jointly modeling 3D chromatin structure, transcriptomics, and epigenomics data while deciphering the distal gene regulatory networks in an individual cell. These studies will enhance our understanding of the function of non-coding regions as regulators of cell fate and infer how the cis-regulatory changes lead to different cell types during development and impact immunotherapeutic treatment.